Resource Core

SUMMARY/ABSTRACT – RESOURCE CORE
The Resource Core of the Center on Causal Data Science for Child and Adolescent Maltreatment Prevention
(CHAMP Center) will play an indispensable role in discovering of new knowledge about factors that both
predict and directly cause maltreatment (Project 1), translating these insights into tools accessible to those in a
position to prevent maltreatment (Project 1), and assessing the validity of these new insights and tools in
scalable interventions tested in field trials (Project 2). It will also inform the dissemination of knowledge, tools,
and educational vehicles for scientists on the application of causal data science to maltreatment exposures
and maltreatment-related outcomes by the Dissemination and Outreach Core. Notwithstanding the tremendous
potential of predictive and causal knowledge that can be scaled, predictive and causal data approaches are not
yet widely used in efforts to anticipate and prevent child maltreatment. Their use requires access to the state-
of-the-art computational infrastructure, deep intellectual and technical skills, and high-quality tools for data
analysis that the Resource Core brings to this Center. Translating the knowledge gained by complex modeling
into decision support tools that can be broadly disseminated also requires specialized expertise. By providing
centralized services to both Projects 1 and 2, while informing the activities of the Dissemination and Outreach
Core and supporting development needs, the Resource Core will play a crucial role in providing the CHAMP
Center with optimally efficient and cost-effective analyses and training.